Center for Biomedical OCT Research and Translation

Project Summary
Polarization-sensitive optical coherence tomography (PS-OCT) was introduced more than 20
years ago but has only recently reached the level of technological maturity needed to support
biomedical translation. Today, PS-OCT is one of the most exciting methods in OCT and
promises to open a new set of doors in applications from intravascular cardiology to nerve-
sparing in surgery. However, specialized phantoms are needed to support the development of
PS-OCT but are not broadly available. Our P41 Center has developed PS-OCT phantoms that
we have used to support our internal PS-OCT development, but which require careful and
unpredictable fabrication methods. Here, we propose modifications and optimizations to the
phantom design to allow these PS-OCT phantoms to be easily made by any group using
broadly available materials. By developing and sharing these phantoms through the NIST/NIBIB
Imaging Phantom Library, this work can act to accelerate PS-OCT development and translation
and to enhance the robustness and interpretability of PS-OCT imaging study results.

Public health relevance
Project Narrative Common imaging phantoms that allow the polarimetric properties of emerging polarization- sensitive optical coherence tomography are needed to support a robust clinical translation of this emerging biomedical imaging technology. The proposed work will optimize and document an imaging phantom addressing this need.